RFA-IP23-002 Adult Immunization Quality Improvement for Providers (IQIP)

PROJECT SUMMARY
This project intends to increase adult immunization through an evidence-based Quality Improvement (QI)
program that combines adult-specific approaches across healthcare provider settings. We will improve
understanding of current adult QI activities, develop an Adult Immunization QI Program (Adult IQIP), and
implement, support, monitor, evaluate and disseminate our Adult IQIP program.

Public health relevance
PROJECT NARRATIVE Vaccination rates among adults are low, especially among vulnerable populations, such as pregnant women, infants, persons with chronic medical conditions, historically marginalized populations, and persons with low income. Increased efforts to vaccinate adults have not been successful. Opportunities for healthcare providers, a trusted source for vaccine information, to educated and immunize their patients are limited by (1) time, (2) possible lack of information on recommendations, efficacy and safety and (3) effective communication approaches. The goal of this project is to develop, evaluate and disseminate an evidence-based Adult Immunization Quality Improvement Program – Adult IQIP - that integrates adult-specific strategies across healthcare provider settings to increase coverage for adults as similar programs have for childhood immunization coverage. To accomplish Aim 1, systematic reviews of the published and grey literature will be conducted; 64 federally funded state, territorial, and local public health immunization programs (IPs) will be surveyed; and site visits will be conducted including Root Cause Analysis. This information will be synthesized to create an Adult IQIP program (Aim 2). To accomplish Aim 3, our Adult IQIP program will be implemented, supported and monitored in 20 adult immunization practices (FQHC/RHC, Free Clinics, Family Medicine) in Virginia and Washington state. Changes in adult immunization coverage, before and after implementation will be determined and compared to control practices. A decision-tree model will be employed to examine longer-term cost effectiveness from a societal, immunization program and practice perspective. Broad dissemination will be accomplished by the Association of Immunization Programs (AIM) and through our professional network of Advisory Committee stakeholders.